Core A: Administrative

PROJECT SUMMARY/ABSTRACT
The Administrative (Admin) Core (Core A) is the coordinating hub of the Emory CFAR with responsibility for
scientific leadership, effective stewardship of resources, investment in innovative HIV research initiatives, and
support for the recruitment of Early-Stage Investigators. This is accomplished through five science cores
(Prevention and Implementation Sciences, Clinical Research, Biostatistics and Bioinformatics, Virology and
Molecular Biomarkers, and Systems Immunology) and two Scientific Working Groups (Health Equity and Next
Generation Therapeutics). Through annual strategic planning, we will evaluate Core services and leverage
resources to ensure the evolving needs of HIV researchers are met. The Admin Core will continue funding
developmental awards and promote training programs to move early-stage investigators to independent
funding through the Developmental Core with a focus on women and underrepresented minorities. We will
strive for effective community engagement in all aspects of the CFAR through greater inclusion of and capacity
building within the CFAR Community Liaison Council. Building on their trailblazing work, we will promote
multidirectional stakeholder engagement to build and sustain trust in HIV research. The Emory CFAR is CoDirected by three distinguished HIV investigators providing complementary expertise across all major areas of
HIV research at Emory. Dr. Carlos del Rio is contact PI and Co-Director for Clinical Science, Dr. Colleen
Kelley is MPI and Co-Director for Prevention Science, and Dr. Ann Chahroudi is MPI and Co-Director for
Basic Science. In the next project period, the Admin Core will be responsible for ensuring that all supported
activities are responsive to the CFAR strategic planning priorities, are broadly advertised, are easily accessible
to investigators, and are regularly evaluated to ensure they are optimally responsive to the evolving needs of
CFAR investigators. To accomplish this, the Core proposes the following specific aims:
Aim 1. Provide scientific leadership and coordinate activities that support CFAR Members as they advance
groundbreaking HIV research across the entire scientific spectrum of NIH-defined priority research areas to
end the epidemic for all and to promote health equity.
Aim 2. Allocate resources effectively and judiciously to support six Cores and two Scientific Working Groups,
providing cutting-edge tools and services to elevate multidisciplinary and translational HIV research.
Aim 3. Develop the next generation of outstanding and diverse HIV investigators through innovative
developmental grant programs, leadership development and mentoring, and promotion of inclusion and
diversity in all aspects of the Emory CFAR.
Aim 4. Utilize intentional communication and dissemination strategies to promote multidirectional stakeholder
engagement between HIV researchers and the communities we seek to serve.